Career Enhancement Program

The goal of this proposed program is to provide funds for career development of faculty members who are or
will be specifically involved in translational research in gastrointestinal cancer. Eligible candidates include
faculty members at any level in the University who wish to direct their efforts into translational research in
gastrointestinal cancer. One Career Enhancement awardee will be selected each year. We anticipate providing
multiple years of support to each awardee. Support for the “out years”, those beyond the maximum supported
time permitted by SPORE guidelines, is provided by institutional funds dedicated to the GI SPORE.

Public health relevance
This Program helps provide the GI Cancer investigators of the future. It supports career development of new investigators or the training needed for established investigators in outside fields to redirect their efforts towards GI Cancer